Preventing Loss of Independence through Exercise in Community Living Centers (PLIE-CLC)

Background: Dementia is a neurodegenerative disorder that is associated with a progressive decline
in cognitive function that slowly robs people of the ability to function independently. Community Living Centers
(CLCs) provide care for approximately 20,000 Veterans with dementia annually, many of whom have comorbid
conditions such as posttraumatic stress disorder and traumatic brain injury that can complicate their care. CLC
staff receive limited training in strategies for engaging residents with dementia in meaningful activities and
managing dementia-related behaviors, and this training gap can result in low quality of life for residents and
suboptimal care. We have developed an innovative group movement program for Veterans with dementia
called Preventing Loss of Independence through Exercise (PLIÉ). The goal of this study is to refine PLIÉ for
CLCs and develop and pilot-test remote staff training procedures so that PLIÉ can be widely implemented.
Significance/Impact. Our proposal is directly responsive to the following 2019 HSR&D Priority Areas:
Long-Term Care/Aging and Population Health/Whole Health. In addition, it employs rigorous implementation
science methods and is designed to address the ORD-wide research priority of increasing the real-world
impact of VA research.
Innovation. PLIÉ capitalizes on recent discoveries in neuroscience, behavioral psychology and
integrative health and shifts the paradigm of care by targeting abilities and neural mechanisms that are
maintained, rather than lost, in the setting of dementia. This includes the ability to learn new movement
sequences through procedural or ‘muscle’ memory; the ability to calm the mind and increase attention through
mindful body awareness and breathing; and the ability to connect in meaningful ways with others. PLIÉ was
originally designed for and tested in adult day programs that contract with VHA, and results to date suggest
that participants are experiencing clinically meaningful improvements in quality of life and mobility
(standardized effect sizes >0.4) and high levels of caregiver satisfaction. In 2017, we received a VA
Innovators Award that enabled us to pilot PLIÉ at the San Francisco VA CLC (PLIÉ-CLC). Participants gave
the program high satisfaction ratings (mean: 4.75 on 5-point Likert scale) and reported noticeable physical and
emotional benefits in themselves and others. SFVA CLC staff are continuing to implement the program with
positive results. Dr. Barnes was nominated for a Federal Executive Board Employee of the Year Award in
2018 for her ground-breaking work on the PLIÉ program.
Specific Aims. 1) To identify barriers and facilitators to implementation of PLIÉ-CLC by conducting
semi-structured interviews with VHA leaders, CLC directors and CLC staff. 2) To refine PLIÉ-CLC to maximize
its scalability and potential for implementation and develop remote training procedures through iterative Plan-
Do-Study-Act (PDSA) cycles at two local CLCs. 3) To assess feasibility and provide proof-of-concept for PLIÉ-
CLC implementation by piloting remote training procedures at 4 CLCs sequentially.
Methodology and Expected Results. This mixed-methods pre-implementation study will include key
informants (Aim 1) and CLC residents, clinical champions and instructor trainees (Aims 2 and 3). The expected
result is that PLIÉ will be successfully adapted for CLCs, that remote training materials and procedures will be
fully developed by the end of the 3-year study, and that pilot data will support the feasibility and potential
clinical benefits of implementation.
Next steps/Implementation: We will seek funding to perform a type II hybrid effectiveness-
implementation study and will work with VHA operational partners (see letter of support from Office of
Geriatrics and Extended Care) to disseminate PLIÉ-CLC nationally, including working with community-based
organizations that provide care to Veterans with dementia and caregivers as part of the MISSION Act.

Public health relevance
Dementia is a devastating brain disorder that slowly robs people of the ability to live and care for themselves independently. Many Veterans with dementia receive long-term care in Community Living Centers (CLCs), which are nursing homes operated by the Veterans Health Administration (VHA). We have developed an innovative group movement program for Veterans with dementia called Preventing Loss of Independence through Exercise (PLIÉ) and are observing beneficial physical and emotional effects in residents and staff at our local CLC. This study will enable us to further refine PLIÉ for the CLC environment (PLIÉ-CLC) and to develop and pilot-test remote training procedures for staff at other CLCs. If this study is successful, we will perform a full-scale implementation study and will work with VHA to disseminate PLIÉ-CLC nationally.